Genome Editing Testing Core

Genome Editing Testing Core
PROJECT SUMMARY / ABSTRACT
The overarching goal of the Genome Editing Testing Core is to test the function of reagents and genome
editing tools developed by investigators funded through other components of the Somatic Cell Genome Editing
(SCGE) Program. The Genome Editing Testing Core will work directly with SCGE awardees and expand
established standard operating procedures (SOPs) and develop new assays for detection of genome editing in
wild-type and reporter nonhuman primates. The Genome Editing Testing Core will test the efficiency and
specificity of editing and will assess the safety and immunogenicity of the genome editing technologies and
delivery systems. The Genome Editing Testing Core has all of the essential facilities and capabilities required
to test a range of viral and non-viral vectors developed by SCGE awardees. The Genome Editing Testing Core
will contribute to the acceleration of the translation of genome editing technologies into treatments for human
diseases through the following Specific Aims: (1) Evaluate genome editing in cells and tissues, (2) Address
safety and the potential for inflammation and immune responses, and (3) Validation of reporter nonhuman
primates. The Genome Editing Testing Core team has the expertise and flexibility to work with investigators to
quantify any desired type of genome editing event in both rhesus macaques and marmosets (e.g., on-target,
off-target, large rearrangements, duration of editing, cell specificity), and in any organ system or cell
population. Paired with a robust Coordination Component and the Resource Core, and through the
infrastructure of the UC Davis Genome Center, California National Primate Research Center, and Clinical and
Translational Science Center, the Genome Editing Testing Core will deliver the data needed to
comprehensively assess the promise of new technologies developed by SCGE awardees.